Regulation of Rotavirus Replication

PROJECT SUMMARY
Our long-term goal is to understand how rotavirus (RV) exploits cellular pathways such as autophagy
membranes, calcium homeostasis, and lipid metabolism including lipid droplet (LD) formation to enhance their
replication and cause life-threatening diarrhea. Despite the global introduction of vaccines for RV over a decade
ago, RV infections still cause >200,000 deaths annually, mostly in low-income countries, highlighting the need
for a more complete understanding of RV pathogenesis. To establish an ideal environment for replication, RV
reprograms the lipid metabolism of the infected cell. We recently discovered that RV infection leads to the
proteasomal degradation of the triglyceride (TG) neutral lipid synthesis enzyme DGAT1 (diacylglycerol O-
acyltransferase1). We found the RV nonstructural protein NSP2 is a new virulence factor that mediates DGAT1
degradation. DGAT1 degradation results in unexpected, enhanced LD formation, elevated TGs, elevated RV
yields, and reduced or a complete loss of expression of intestinal digestive or absorptive enzymes, or proteins
required for intestinal epithelial structure and function. Thus, NSP2-induced DGAT1 degradation is a new
underlying mechanism of intestinal malabsorption and diarrhea. Another consequence of RV reprogramming of
cellular lipid metabolism is the induction of cytoplasmic organelles (viroplasms) formed by two viral nonstructural
proteins NSP2 and NSP5 and LDs that form a physical platform for efficient viral replication and maturation. LDs
are dynamic, multi-functional intracellular organelles involved in lipid storage and metabolism as well as in signal
transduction, membrane trafficking and modulation of immune and inflammatory responses. LDs play essential
roles in several viral and intracellular bacterial infections and are important in many aspects of health and disease
(metabolism, diabetes, obesity, heart disease). However, mechanistic information of the interplay between lipid
accumulation, and the cellular sites and proteins required for LD biogenesis is far from complete. We propose to
build on our exciting new findings to define basic mechanisms regulating lipid metabolism including DGAT1
degradation and LD formation in the intestine using RV as a model pathogen and human intestinal enteroids as
a human intestinal model. We propose experiments to answer two questions. (1) What molecular mechanisms
trigger NSP2-induced DGAT1 degradation leading to malabsorptive diarrhea? (2) What mechanisms elicit RV-
mediated lipid reprogramming responsible for increased TG and LD biogenesis required for virus
assembly/replication and pathogenesis? These studies are significant because viral perturbations of host
signaling and metabolic pathways that involve LDs are critical for multiple pathogens. Because RVs replicate in
enterocytes in the tips of the villi in the small intestine, the major site of fat absorption critical for energy
production, membrane biosynthesis and brain development, our studies may explain why RV-induced
gastroenteritis causes more severe, life-threatening disease compared to other enteric infections, and why
children exhibit delayed growth and cognitive ability if they survive their RV-intestinal and diarrheal insult.

Public health relevance
PROJECT NARRATIVE Rotavirus (RV) infections kill >200,000 young children globally in spite of the introduction of vaccines, highlighting the importance for continued study of this pathogen. Our proposed studies are designed to understand how RVs take advantage of key host cellular pathways involved in the accumulation of fat (lipid) to form specialized sites in the infected cell critical for virus replication and viral-mediated degradation of a cellular protein that results in diarrhea. We expect the knowledge gained from our studies will help (1) understand how RVs and many other viruses cause disease, (2) explain why RV infections in children become life-threatening, and (3) lead to new treatment and antiviral therapies.